A multiplexable in vivo perturbation toolkit to identify genes affecting neurodegeneration in a model of synucleinopathy

Project Summary/Abstract
Neurodegenerative disorders such as Alzheimer’s disease (AD), Parkinson’s disease with dementia (PDD) and
dementia with Lewy bodies (DLB) have no cure, but all three share signs of α-synuclein (α-syn) pathology and
a pattern of neurodegeneration in which there is variation in neuronal loss. Our long-term goal is to examine
this differential neuronal susceptibility to identify features of neurodegeneration in synucleinopathy, and to use
this knowledge for subsequent development of neuroprotective strategies and biomarkers. Our central
hypothesis is that CRISPR-Cas9 library screening can be used as a cell-type specific, high-throughput in vivo
method to elucidate determinants of neurodegeneration in synucleinopathy. The rationale for the proposed
research is that, once susceptibility modifiers are identified, therapeutic strategies can be devised for the
treatment of PDD, DLB and even perhaps AD. Thus, in AIM 1, we propose to begin by identifying candidate
modifiers of neuronal susceptibility in the transgenic mThy1-α-syn (L61Tg) mouse model of synucleinopathy
using cell-type-enriched single-nucleus profiling of dopaminergic (DA) neurons. Given the known differential
susceptibility among ventral midbrain DA neurons in synucleinopathies, we posit that transcriptomic profiling of
these neurons will not only identify signatures of neuronal resilience to stress, but also identify candidate
modifiers for inclusion in our subsequent CRISPR library screen. For this work, our cell-specific nuclei tagging
system will allow to selectively profile, by single-nucleus RNA-sequencing, DA neurons in L61Tg and their non-
transgenic (NTg) littermates. The resulting sequencing data will then be clustered and investigated using
differential composition and gene expression analysis to generate a final set of candidate genes that are
expressed in subsets of DA neurons, differentially regulated in L61Tg mice, and relevant to human DA
subtypes. These candidate genes, which will be included in the list of perturbation candidates in AIM 2, will
also serve as a set of genes for future investigations in neurodegeneration research. Next, in AIM 2, we will
perform a targeted in vivo CRISPR library screening of DA-neurons in the same mouse model of
synucleinopathy. Here, single guide RNA (sgRNA) libraries will be delivered by systemic AAV injection, before
brains are harvested six months later and processed for sgRNA sequencing, to identify which genes from our
list, upon being silenced, are functional modifiers of neuronal loss. The candidate gene list will be made of our
reported hits (Brichta et al., Nat Neurosci, 2015) and those identified in AIM 1. Successful completion of this
project will reveal determinants of neuronal survival in vivo and in response to α-syn, a stressor relevant to
human neurological disorders. Thus, our anticipated results will have an important positive impact as they will
provide opportunities for preventive and therapeutic interventions and, fundamentally, advance our mechanistic
understanding of PDD, DLB and even perhaps AD.

Public health relevance
Why some cells die while other survive in the brains of patients with synucleinopathies remains uncertain. Herein, we propose to use a new gene editing technology to elucidate the mechanisms driving cell resilience in these neurological disorders. If successful, this strategy may have far-reaching implications for the treatment of synucleinopathies and even perhaps Alzheimer's disease.